Development of Safe and Sustainable Systems of Enhanced Bioremediation of PAH Mixtures

PROJECT SUMMARY – SEMPRINI PROJECT
The goal of this project is to create novel, safe, sustainable systems that treat PAH mixtures while minimizing
the formation of hazardous PAH breakdown products. Our approach is to immobilize microbial cultures in
hydrogel beads. We will learn to associate primary and secondary PAH transformation products with specific
bioremediation technologies, then help stakeholders select the most effective bioremediation technologies for
their sites.
This project challenges the common assumption that the contamination problem ends when parent PAHs
degrade. We will develop novel biological techniques to treat PAH mixtures from contaminated sediments and
soils from the Portland Harbor Superfund Site (PHSS). We will reduce toxicity from parent PAHs via microbial
processes while monitoring the appearance and the toxicity of degradation products. To identify and measure
the products formed during the transformation process, we will rely on advanced targeted and non-targeted
high-resolution mass spectrometry methods paired with fractionation and high-throughput effect-directed
analysis.
We will isolate bacterial cultures from a Superfund site that promote cometabolic or metabolic transformations
of PAH mixtures. We will compare the transformation abilities of those cultures with cultures we have studied
previously.
We will apply our hydrogel technology to create permeable reactive biological barriers (PRBB) that treat PAH
mixtures in situ. We also plan to test an ex-situ bench-scale system in which we apply hydrogels to treat soil
washing solutions that contain PAH mixtures. Since the biological processes occur within the hydrogel beads,
mixtures of beads with different microbes can promote the more complete transformation of PAH mixtures to
non-toxic products. We plan to incorporate cultures grown in the presence of PAH mixtures obtained from
passive samplers at the PHSS into hydrogel beads for the proposed treatment technologies. We will track the
transformation of parent PAHs by GC-MS and UPLC-HRMS methods developed in our past projects.
We will evaluate the reduction or increase in toxicity of the transformation products of PAH mixtures in
fractionated and non-fractionated samples in collaboration with the Tanguay Project (via the in vivo embryonic
zebrafish assay) and the Tilton Project (via the in vitro human lung cell assay). We will correlate bioactivity in
sample fractions with accurate masses detected in parallel via UPLC-HRMS. This approach will allow us to
identify corresponding structures of masses in active fractions via non-target analysis and suspect screening. We
will identify peaks that covary with observed biological effects and attribute these peaks to candidate causative
chemicals.

Public health relevance
PROJECT NARRATIVE – SEMPRINI PROJECT This project aims to develop novel in situ and ex situ biological treatment systems to treat PAH mixtures in contaminated sediment and soil. We propose to create hydrogel beads that contain immobilized bacteria cultures extracted from a contaminated site and will apply those hydrogel beads to create permeable reactive biological barriers for contaminated sediments and to treat soil washing solutions ex situ. We will track transformation products via high-resolution LC-MS as we treat PAH mixtures.